EFFECTS OF DIET COMPOSITION ON ENERGY EXPENDITURE AND SUBSTRATE OXIDATION

This study examines how total energy expenditure and oxidation rates of protein, fat, and carbohydrate change when subjects are placed for seven days on high fat (65% of calories from fat) and high carbohydrate (65% of calories from carbohydrate). Energy expenditure and oxidation rate are measured using a whole room indirect calorimeter.